Integrative Microbiology Program

PROJECT ABSTRACT
Now in its 20th year, The UCSF Microbial Pathogenesis and Host Defense (MPHD) program, which we have
renamed the Integrative Microbiology (iMicro) program to better reflect the role of microbes in health and disease,
provides a comprehensive, world-class training plan to prepare graduate students and postdoctoral fellows for
future careers in academics, industry, public health, or teaching. Rapid scientific advances in microbiology and
infectious disease have provided unprecedented opportunities to improve the health of mankind worldwide. The
importance of training our next generation of scientific leaders to use innovative tools to interrogate human-
related microbiology has never been greater. UCSF hosts an unusual number of world-class laboratories
applying systems biology approaches, state-of-the art genetics and cell biology, and structural biology to the
study of microbes (including bacteria, viruses, fungi, parasites) and innate immunity. Indeed, the iMicro program
catalyzes new scientific directions and broadens training opportunities by bringing together microbe-focused
laboratories with those from diverse scientific fields to create an interdisciplinary program focused on issues in
host-microbe interactions. Additionally, UCSF has been a leader in development and application of technological
advances that are revolutionizing microbiology, including metagenomics, high resolution microscopy, and
molecular and metabolic analysis of the microbiome. Excellent institutional core facilities are available to
accelerate application of new and emerging technologies. The 27 faculty have an exceptional track record of
creative and high-profile research, superb mentoring, and robust research funding, and thus attract an elite group
of trainees. The iMicro program is open to all UCSF graduate students and postdoctoral fellows who express an
interest in microbial research. The program is comprised of the following program-specific components: (i) a
weekly seminar series composed of outside invited speakers as well as trainee research-in-progress talks; (ii) a
yearly Bay Area-wide Microbial Pathogenesis (BAMPS) symposium now in its 26th year; (iii) graduate student
elective courses that provide a diverse curriculum in microbes in health and disease; (iv) an internal trainee
retreat; (iv) an individualized postdoctoral mentoring program that augments the already high caliber of
postdoctoral training by matching fellows with a secondary mentor other than their PI. The program has an
outstanding track record of successful predoctoral and postdoctoral trainees, including those who are from
underrepresented groups (URGs): In the past 5 years, 24% of the iMicro-supported trainees were URGs and
76% were women, while 33% of iMicro-supported postdoctorates were from URGs and 71% were women. In
sum, the collective activities of the iMicro program provide an outstanding training opportunity for graduate
students and postdoctoral fellows who seek to understand the role of microbes in human health and
pathogenesis.

Public health relevance
PROJECT NARRATIVE The application proposes to continue a highly successful training program, Microbial Pathogenesis and Host Defense, renamed Integrative Microbiology (iMicro), which was initiated 20 years ago. UCSF hosts world-class laboratories studying all aspects of microbes in health and disease, including bacteria, fungi, parasites, and viruses. Our central goal is to provide an interdisciplinary environment and rigorous specialized training for the next generation of leaders who will endeavor to understand how microbes influence mammalian biology and to reduce the worldwide burden of infectious disease.